Cancer cell selective killing nanoparticle for advanced ovarian cancer treatment

PROJECT SUMMARY
Ovarian cancer is the fifth most common cause of cancer-related deaths in women and results in more deaths
than any other cancer of the female reproductive system. The primary reason for the high death rate of ovarian
cancer is multidrug-resistance. Since conventional anticancer drugs cannot kill drug-resistant cells while causing
systemic toxicity to deteriorate patient health condition, a novel effective and safe treatment for ovarian cancer
is urgently needed. Our preliminary study has discovered a novel polymer-metal combination which uniquely
induces a lysosomal copper elevation initiated intrinsic apoptosis pathway. Consequently, this combination is
highly selectively in killing cancer cells, including drug-resistant ovarian cancer cells, while not
damaging healthy cells. The objective of this research is to develop a polymer-metal nano-complex (PMC) for
safe and effective ovarian cancer therapy through a cancer cell selective apoptosis mechanism. Our project has
three specific aims. In Aim 1, we will identify the mechanism of cancer cell killing effect of PMC. Aim 2 will identify
the cancer selective killing mechanism of PMC and optimize its formulation to achieve the highest selectivity for
cancer cells. Aim 3 will investigate the pharmacokinetic properties, examine the biodistribution of PMC, and
evaluate its tumor growth inhibitory effect, immune response, and systemic toxicity. In summary, the unique
anticancer mechanism of PMC and its simple formulation will provide clinicians a safe and effective tool to control
advanced ovarian cancer and benefit ovarian cancer patients.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Ovarian cancer is the most prevalent mortality from a gynecologic malignancy in US, which results in a pressing need for the development of new treatments for ovarian cancer. This research will develop a polymer-metal nano-complex for the treatment of advanced ovarian cancer through selectively kill cancer cells, including drug-resistant cancer cells, while sparing normal cells. The success of validating this concept will pave the road to take it forward to clinical trial and lead to the control of ovarian cancer.